Randomized Trial to Optimize Virologic Suppression Rates Using a Point-of-Care Urine Monitoring Assay (ROVING-PUMA)

PROJECT SUMMARY/ ABSTRACT
Although World Health Organization (WHO) guidelines now recommend once‐daily tenofovir‐lamivudine‐
dolutegravir (TLD) for antiretroviral therapy (ART), adherence challenges in taking daily oral ART persist. The
rates of virologic suppression (VS) worldwide for those on ART are around 70%, with a lower rate (65%)
approximately three years after starting ART. Pharmacologic adherence metrics, where ART levels are directly
measured in a biomatrix ‐ such as plasma, urine, dried blood spots (DBS), or hair‐ reflect actual pill‐taking and
predict virologic suppression more accurately than self‐reported adherence. Our UCSF research group has
helped pioneer the use of small hair samples to measure adherence to ART, but most methods to analyze ART
drugs in any matrix involve liquid chromatography/tandem‐mass spectrometry (LC‐MS/MS) which is
expensive and cannot be performed in real‐time. Point‐of‐care (POC) adherence monitoring requires the
development of a highly selective antibody and subsequent development of an immunoassay to ART.
Evidence from other disease states show that real‐time monitoring of drug levels to the needed
medication, followed by supportive feedback to the patient, increases adherence and improves outcomes.
Our UCSF group has now developed one of the first immunoassays (antibody‐based assay) to detect
tenofovir (TFV) in urine, a matrix easily‐accessible for point‐of‐care testing. Work by our team among people
with HIV (PWH) in Namibia assessed the effect of the urine assay on VS rates among persistently virally non‐
suppressed adults on ART, despite the application of WHO‐recommended enhanced adherence counseling
(EAC). In a pre‐post analysis, we found that VS rates increased from 0% to 92% after urine testing and
counseling at monthly ART refills over six months. Now is the time to perform a large, randomized trial to
explore the ability of counseling informed by results from the urine TFV assay to increase VS versus
standard‐of‐care EAC to provide evidence for incorporating the urine POC test into clinical practice.
Aim 1 of this renewal R01 application proposes a large randomized trial (n=500) comparing use of the
POC urine test for TFV with tailored counseling versus standard‐of‐care EAC among participants with
documented virologic failure on TLD at clinics in South Africa. The primary outcome is VS at six months;
secondary outcomes include assessing the sustainability of the 6‐month intervention on VS out to 24 months;
development of viral resistance in each arm; and positive urine tests by arm. Aim 2 examines implementation
outcomes including acceptability and feasibility, with Aim 3 assessing cost‐effectiveness of the intervention. If
the trial is successful, we will have demonstrated that an easy‐to‐use inexpensive POC urine adherence test
will increase VS among populations with virologic failure on TLD, which will benefit patients, decrease the
development of viral resistance, and prevent forward transmission. The aspiration of this grant is to move the
low‐cost urine assay into clinical care and inform WHO ART guidelines (WHO letter of support included).

Public health relevance
PUBLIC HEALTH RELEVANCE/ PROJECT NARRATIVE Although we now have once-daily oral treatments for HIV with tenofovir-lamivudine-dolutegravir (TLD) globally, it can be difficult to take a pill every day for HIV and virologic suppression rates around the world for those who are on treatment are around 65-70%; we want to improve those rates to get to the goals of improving lives for people with HIV, reducing the development of drug resistance, and preventing HIV via “undetectable=untransmittable”. We developed in our research group a urine-based test that can detect tenofovir via an immunoassay (which looks like a pregnancy test) and found that counseling around this test in Namibia for those who did not suppress their virus on TLD improved virologic suppression from 0% to 92% in a small study. We now propose a large randomized trial where we will compare standard adherence counseling recommended by the World Health Organization to adherence counseling tailored to the results of the urine tenofovir assay in South Africa to see if the urine assay increases virologic suppression rates in those who don’t suppress at first; if the trial works and the easy-to-use, inexpensive urine assay is cost-effective, the data from this grant will hopefully move the urine tenofovir test into routine clinical care for people with HIV.